Optimizing the restoration and rehabilitation of function using cortically-controlled FES following SCI

Despite the long-­term promise of stem-­cell and other biological approaches, current options to improve
function following spinal cord injury (SCI) remain quite limited. However, brain machine interfaces (BMIs) that
use cortical activity to drive functional electrical stimulation (FES) of muscles or the spinal cord have great
promise not only for the restoration of motor ability when using the BMI, but also for improved functional
rehabilitation so that their performance is improved when the BMI is removed. The overall goal of our research
is to identify strategies that maximize both of these potential strengths of cortically-­controlled FES.
A system using cortical activity to drive stimulation of individual muscles might maximize the restoration
of motor function: by enabling users to vary the amplitude and timing of individual muscles, movements can
potentially be adapted as necessary to achieve task demands. Alternate strategies of producing movement,
such as activation of muscle groups or of sites in the spinal cord producing limb flexion or extension, will
reduce the range of possible movements. Although these strategies might be simpler to learn after SCI than
control of individual muscles, they clearly limit the level of motor function that can be restored.
In order to achieve the greatest functional rehabilitation, however, spinal stimulation might be a more
promising strategy than muscle stimulation. Repeated spinal stimulation might maintain the function of spinal
pathways involved in the production of movement and enable restoration of connections from descending
systems through associative plasticity. Conversely, since muscle stimulation does not activate spinal pathways
to produce movement, it might produce less functional rehabilitation.
There is therefore a potential tradeoff between muscle and spinal stimulation: muscle stimulation enables
high levels of motor ability but might limit functional rehabilitation, while spinal stimulation might enhance
rehabilitation but limit flexibility. Our research will investigate this tradeoff, with the goal of designing a hybrid
system that combines spinal and muscle stimulation to achieve high levels of both motor ability and functional
rehabilitation.
We will perform these experiments in rats, implanting electrodes in the cortex to record neural activity
and in the spinal cord and muscles to produce movements. We will then train rats to use these systems after
SCI, evaluating whether they can improve motor ability and functional rehabilitation. In Aim 1, we will evaluate
whether animals can produce high levels of motor ability with a system using cortical activity to control activation
of individual muscles. In Aim 2, we will evaluate whether animals using cortical activity to control activation of
spinal stimulation have better functional rehabilitation. Finally, in Aim 3 we will evaluate whether a hybrid system
that controls activation of both muscle and spinal stimulation, exploits the advantages of each approach to
produce movement, resulting in high levels of both motor ability and of functional rehabilitation.

Public health relevance
Project Narrative The experiments in this proposal will work to optimize a novel system for improving motor function in people with spinal cord injury. This system uses the activity of neurons in the brain to estimate the movement people intend to make, then produce this movement by activating muscles in the person’s own limb. We will identify designs that maximize the functional improvements produced by this system.